DIAN Neuropathology Core

The major goal of the Dominantly Inherited Alzheimer Network Neuropathology Core (DIAN-NPC) is to provide a neuropathological diagnosis on all participants in DIAN and family members who come to autopsy, to exchange data with the DIAN Coordinating Center, and to provide diagnostic reports and tissues to collaborating sites. The DIAN-NPC provides the

Public health relevance
Although there have been tremendous advances in the development of biomarkers of Alzheimer’s disease, there remains no reliable method for showing the earliest pathological changes in the brain or the presence of additional pathology which may contribute to the progression and symptoms of the disease. The Neuropathology Core of DIAN is essential to provide a neuropathological diagnosis on all participants and family members who come to autopsy - it is the gold standard against which all biomarker and clinical assessments are judged. The importance of the Neuropathology Core is demonstrated by the observation that in DIAN participants there often is additional Lewy body disease that was not detected by any biomarker, clinical or other assessment and likely contributes to the rate and nature of the cognitive and motor impairment in vulnerable individuals.